Gene regulation from the inactive X in activated B cells

Project Summary
The X-chromosome is enriched with immunity-related genes, therefore X-linked genes need to be regulated to
prevent abnormal expression. Females use X-chromosome Inactivation (XCI) to equalize X-linked gene
expression, where one X maintained transcriptionally silent by continuous expression of the long noncoding
RNA Xist and enrichment of heterochromatin modifications. We have recently discovered that female
lymphocytes have a unique and dynamic mechanism to maintain XCI, unlike other somatic cells. Resting
mature B cells lack Xist RNA and heterochromatin marks on the Xi, and these modifications return to the Xi
through a YY1-mediated mechanism upon stimulation. Our in-press work indicates that preventing Xist RNA
localization to the Xi by conditional knock-out of YY1 impairs heterochromatin enrichment on the Xi, and
increases X-linked expression. In preliminary work, we found that B-cell specific deletion of one Xist allele
(mb1CRE XistCKO/+) dramatically reduced Xist localization patterns over the Xi, reduced heterochromatin
enrichment, and increased expression of specific X-linked genes. Moreover, this increase in X-linked gene
expression was accompanied by increased antibodies to double-stranded DNA, a hallmark of autoimmunity.
We hypothesize that Xist RNA localization to Xi is required to keep Xi at the nuclear periphery to maintain
transcriptional repression in activated B cells, and that failure to localize Xist RNA disrupts Xi nuclear
organization and perturbs X-linked gene expression, with consequent predisposition to autoimmunity. We will
test our hypothesis with the following aims: (1) Do temporal and sequence-specific occupancy of YY1, Xist
RNA, and heterochromatin marks on the Xi maintain transcriptional repression in activated splenic B cells? (2)
Do chromosome structural proteins cooperate with YY1 to localize Xist RNA within Xi territory at the nuclear
periphery for transcriptional repression in activated splenic B cells? (3) Are Cxcr3, Itm2a, Syn1 and Cfp
overexpressed in lupus mouse models and does increased dosage predispose to autoimmunity? IMPACT: The
results from these experiments will yield fundamental insight about the lymphocyte-specific mechanisms that
regulate expression from the Xi, and will advance our understanding of the female-bias underlying B cell
mediated autoimmune disorders.

Public health relevance
Project Narrative Females are biased to develop autoimmune disorders, suggesting a genetic basis in the X-chromosome, which has the highest number of immunity-related genes. We have identified a novel, female-specific mechanism of gene regulation from the X-chromosome unique to B cells, and this research proposal investigates the molecular details of how X-linked genes are regulated from the inactive X chromosome. Our findings will elucidate how X-linked genes become aberrantly overexpressed in diseases involving female B cells.